Genetic Investigation of Covid 19 in Lung Disease

Project Summary
Lethal COVID-19 disease caused by the beta-coronavirus SARS-CoV-2 is manifest as
respiratory distress associated with a rapid decline in blood oxygen saturation levels, though other
organ defects are often described in patients and clinical case series. Descriptive studies of human
patients have proposed numerous pathogenic mechanisms for these findings, including direct
epithelial cell infection, vascular cell infection and thrombosis, and released inflammatory cytokines.
However, these hypotheses remain purely correlative as causality cannot be rigorously established in
human patients. Mouse genetic approaches have not yet been harnessed to test COVID-19
pathogenic mechanisms. To address this gap in knowledge we generated new mouse genetic models
that express hACE2 from the mouse Ace2 locus at levels sufficient to confer lethal disease, hypoxia,
and pulmonary vascular thrombosis like that observed in human patients.
The parent grant initially proposed to work on vascular mechanisms of these phenomenon,
including to 1.2) Determine the epithelial cell lineages necessary for either acute ARDS phenotype or
long term lung damage by SARS-CoV2 infection; 1.3) Define the contribution of vascular cell infection
for either acute ARDS phenotype or long term lung damage by SARS-CoV2 infection; and 3) Compare
and contrast the lung vascular and thrombotic effects of influenza versus SARS-CoV-2.
Subsequently, we have explored the mechanism of COVID-19 on pulmonary intravascular
thrombosis using the PAR1-Tango reporter allele bred with our hACE2 mice, and have observed
abnormal PAR1-Tango activity in the vascular beds of multiple organs (lung, kidney, liver) following
SARS-CoV-2 infection, which is unexpected since obvious thrombi are only present in the lungs.
Besides these new findings, we have also learned using Cre/lox-mediated endothelial deletion of
hACE2, that vascular infection by SARS-CoV-2 is not likely responsible for any major phenotypes we
observed. This supplement proposes additional work in order to: a) reveal the extent and severity of
vascular injury in COVID-19 disease, using PAR1-Tango specimens; b) understand the actual
mechanisms of thrombin generation in SARS-CoV-2 infection by employing an extensive multi-organ
immunohistological survey; and c) confirm sources of pro-thrombotic or inflammatory factors using
RNA sequencing from the tissues and/or regions of interest. As the majority of specimens are already
collected, but awaiting in-depth analysis, the supplement is well-suited to extend the work of the
parent grant, but within its original scope. Additional equipment or reagents are not needed to pursue
these studies, which instead require the time and effort of the candidate together with resources
already available in the Kahn laboratory.

Public health relevance
Project Narrative Vascular pathology and intravascular coagulation are cardinal features of COVID-19 disease, and lung pathologies are associated with a very high rate of intravascular thrombosis both in humans and non-human primates. To address critical gaps in knowledge in COVID-19 pathophysoiology, we have generated new mouse models that sustain lethal COVID-19 disease and exhibit pulmonary vascular thrombosis as well as disseminated thrombin generation. By combining histological and genomics techniques, we will investigate the source of this thrombin, as well as the mechanisms surrounding its production and release.